MUCOSAL STRATEGIES FOR GENERAL IMMUNITY AGAINST SEXUALLY TRANSMITTED DISEASE

To understand the potential influences of endogenous and exogenous hormones and other agents on the immune function of the female reproductive tract. This will provide a foundation for future studies including various immunization protocols to induce immune responses in human gential tract. We will compare the immunologic effect of a number oa agents on samples of blood, saliva cervico-vaginal fluids and some tissue samples (servical Biopsy) that we obtain at different times of the menstrual cycle and/or reporductive life.